National IDeA Symposium of Biomedical Research Excellence - NISBRE

L O UI S I AN A S TA T E U N IV E R S ITY
A N D A G R I C U L T U R A L A N D M E C H A N I C A L C O L LEGE
School of Veterinary Medicine (SVM)
Department of Pathobiological Sciences (PBS)
Division of Biotechnology & Molecular Medicine (BioMMeD)
March 25, 2025
To: Jessica M. Faupel-Badger, PhD, MPH
Chief, Networks and Development Programs Branch
Division for Research Capacity Building
National Institute of General Medical Sciences (NIGMS)
National Institutes of Health
US Department of Health and Human Services
Email: [email]
Through: Samantha Farrell, MHS
Grants Management Specialist
NIGMS National Institutes of Health (NIH)
45 Center Dr., Rm. 2AN36A, MSC 6200
Bethesda, MD 20892-6200
Email: [email]
Re: Request for Administrative Supplemental Funds (PA-20-272) for NIH: NIGMS
UGM143856A “National IDeA Symposium of Biomedical Research Excellence (PI: Kousoulas,
K. G.)
We request $100,000 administrative supplemental funds in the year 4 for the above-mentioned
grant to pay costs associated with IT contractual services for the NISBRE2026 conference and
travel needs for the collaborating LSU and UNL teams. The current year 4 budget is $65,286.
allocated to LSU and UNL personnel working on the project. It is insufficient to support IT
contractual agreements and travel-associated expenses for the LSU and UNL to plan for the
conference. Specifically, we request the following funds.
1) We request administrative funds in the amount $20,000 for travel and supplies for LSU
and UNL personnel for current year to finalize the venue for NISBRE2026 in Maryland,
Bethesda (budget and justification attached). We anticipate three personnel from UNL
and LSU visiting the venue at least twice in year four.
2) We request administrative supplement funds in the amount of $80,000 for contractual
arrangements for IT support for website and other necessary logistics for the current year
to finalize the website and start the registration process (budget and budget justification
attached).
Sincerely,
Gus Kousoulas, PhD, Hannelore, and Hans Storz Distinguished Professor
Head, Department of Pathobiological Sciences
Principal Investigator, Louisiana Biomedical Research Network (LBRN)
Director of the Division of Biotechnology & Molecular Medicine (BIOMMED)
School of Veterinary Medicine
Louisiana State University, Baton Rouge, LA 70803
Email: [email]. Cell: 225-205-2444
https://lbrn.lsu.edu
Baton Rouge, Louisiana 70803 (225) 578-9911 Fax (225) 578-9655

Public health relevance
L O UI S I AN A S TA T E U N IV E R S ITY A N D A G R I C U L T U R A L A N D M E C H A N I C A L C O L LEGE School of Veterinary Medicine (SVM) Department of Pathobiological Sciences (PBS) Division of Biotechnology & Molecular Medicine (BioMMeD) March 25, 2025 To: Jessica M. Faupel-Badger, PhD, MPH Chief, Networks and Development Programs Branch Division for Research Capacity Building National Institute of General Medical Sciences (NIGMS) National Institutes of Health US Department of Health and Human Services Email: [email] Through: Samantha Farrell, MHS Grants Management Specialist NIGMS National Institutes of Health (NIH) 45 Center Dr., Rm. 2AN36A, MSC 6200 Bethesda, MD 20892-6200 Email: [email] Re: Request for Administrative Supplemental Funds (PA-20-272) for NIH: NIGMS UGM143856A “National IDeA Symposium of Biomedical Research Excellence (PI: Kousoulas, K. G.) We request $100,000 administrative supplemental funds in the year 4 for the above-mentioned grant to pay costs associated with IT contractual services for the NISBRE2026 conference and travel needs for the collaborating LSU and UNL teams. The current year 4 budget is $65,286. allocated to LSU and UNL personnel working on the project. It is insufficient to support IT contractual agreements and travel-associated expenses for the LSU and UNL to plan for the conference. Specifically, we request the following funds. 1) We request administrative funds in the amount $20,000 for travel and supplies for LSU and UNL personnel for current year to finalize the venue for NISBRE2026 in Maryland, Bethesda (budget and justification attached). We anticipate three personnel from UNL and LSU visiting the venue at least twice in year four. 2) We request administrative supplement funds in the amount of $80,000 for contractual arrangements for IT support for website and other necessary logistics for the current year to finalize the website and start the registration process (budget and budget justification attached). Sincerely, Gus Kousoulas, PhD, Hannelore, and Hans Storz Distinguished Professor Head, Department of Pathobiological Sciences Principal Investigator, Louisiana Biomedical Research Network (LBRN) Director of the Division of Biotechnology & Molecular Medicine (BIOMMED) School of Veterinary Medicine Louisiana State University, Baton Rouge, LA 70803 Email: [email]. Cell: 225-205-2444 https://lbrn.lsu.edu Baton Rouge, Louisiana 70803 (225) 578-9911 Fax (225) 578-9655